Prospective analysis to determine model accuracy performance and boundaries in the post-AlphaFold2 environment

Experimental determination of protein structure often provides atomic accuracy models, but is inherently time-
consuming, costly, and not always possible. Computational modeling offers an alternative. Recent application of deep
learning methods to structure modeling now allows the generation of highly accurate models of structure for the great
majority of single proteins. Progress in modeling accuracy for the modeling of protein complexes is also expected in the
near term. These developments have dramatically expanded the utility of models in biology and medicine.
However, having even high accuracy models at one’s disposal is not the same as an experimental result. While
experimental structures come with established norms and procedures to ascertain accuracy, models are at best annotated
with predictions of accuracy. The increased use of models underscores the need for similar knowledge, norms, and
procedures for models. The Critical Assessment of Structure Prediction (CASP, funded by the parent grant), is already
focused on assessing performance of modeling techniques and the performance of methods for estimating model
accuracy, and to this end, extensive additional data are currently being acquired as part of the CASP15 experiment. But a
detailed assessment of accuracy and accuracy prediction properties under an adequate range of conditions requires more
extensive information than will be available through traditional CASP procedures. The release of close to a million models
obtained with the AlphaFold2 method from DeepMind has created an opportunity to perform such an analysis.
We will use these data to perform a prospective analysis of model accuracy and accuracy prediction performance.
Specifically, we will compare structures released by the PDB with the corresponding previously deposited models. We will
assess the agreement between these experimental and computed structures, both overall and at the individual amino
acid level, and the agreement between the predicted and actual accuracy. Critically, we will examine these factors as a
function of the relevant variables, particularly the quality and type of the experimental information, environmental effects
such as crystal packing, function related structural features, rare structural features, protein interface regions, sequence
length, and the depth of the available amino acid sequence alignment used to generate the model. We will also build tools
to analyze and visualize the relationships and interdependencies between these data, to facilitate and expand our
understanding of model accuracy performance. The overall goal of this work is to provide a fine-grained landscape of
accuracy obtained with current modeling methods, and confidence limits on accuracy in each situation. Although the
present analysis is restricted to AlphaFold2 models, identification of the most important variables should allow us to apply
the procedures to the range of methods represented in the smaller data sets obtained in regular CASP experiments, and
to new applications of deep learning methods in structural biology, for example the modeling of protein complexes.
The infrastructure and expertise we already have in place, including the wide range of accuracy analysis tools, and
our extensive experience with accuracy, accuracy estimation methods, and database management, make us the
appropriate group to address this task. The proposed research falls well within the scientific scope of the current R01.

Public health relevance
PROJECT NARRATIVE Knowledge of macromolecular structure plays a crucial role in biology and medicine, allowing for detailed studies and understanding of biological processes and disease mechanisms. Yet, relatively few structures are obtained experimentally - the rest must be modeled. The proposed modification to the Critical Assessment of Structure Prediction program (CASP) provides a means for better understanding the accuracy of the now broadly available genome-scale sets of protein structure models.